Role of energy balance behaviors in modifying biobehavioral risk factors for childhood obesity

Obesity
environmental
children,
key
between
the
to
of
independent
resource
hyperphagic
absence
aggregate
aims
sleep
and
the
is a multifactorial disease which results from complex interactions among multiple genes, behaviors, and
factors. A heightened genetic risk does not always translate to the development of obesity among
which points to the presence of risk-modifying factors that likely relate to energy balance behaviors as
behavioral drivers. This study will build on our prior research to comprehensively examine t he interplay
genotype and phenotype and, for the first time, systematically assess if energy balance behaviors in
context of the family environment, alone or in combination, can modify behavioral and genetic predispositions
childhood obesity. Specifically, this research aims to prospectively evaluate the extent to which associations
a heightened drive to eat (HDE) n 1-year changes in weight and adiposity outcomes are
or additive to those of a genetic risk for obesity among children, ages 5 to 7, from f amilies with low-
backgrounds. HED will be conceptualized as a broader behavioral phenotype which combines
appetitive traits (i.e., the relative reinforcing value of food, a rapid eating rate, and eating i n the
of hunger). Children's genotype will be assessed using a genetic risk score (GRS), which serves as an
measure from multiple obesity risk single nucleotide polymorphisms (SNPs). In addition, the study
to prospectively examine risk-modifying energy balance behaviors in areas of diet, physical activity, and
that may mitigate the detrimental impact of a HDE or high genetic risk on weight and adiposity outcomes
test whether these factors differ for HDE versus a high genetic risk of obesity on those outcomes. Lastly,
research aims to e
o
xamine the impact of family-level influences in areas of family functioning and parent
feeding on risk-modifying energy balance behaviors in children. Primary outcomes will include 1-year changes
in children's body mass index (BMI) z-score, percent body fat, and waist circumference. Identifying
and
moving
research
family-based
behavioral
family factors that may mitigate the impact of obesity risk on weight and adiposity outcomes is critical for
the prevention of childhood obesity into a new direction. If successful, the knowledge gleaned from this
will offer new and powerful targets for addressing health disparities in obesity and formulating tailored
interventions in the fight against childhood obesity.

Public health relevance
Public Health Relevance: A genetic risk for obesity does not always translate to the development of obesity among children, which points to the presence of risk-modifying factors that likely relate to energy balance behaviors as key behavioral drivers. Using an integrated approach to comprehensively examine the interplay between genotype and phenotype, this study will systematically assess the extent to which energy balance behaviors, alone or in combination, in conjunction with family-level influences can modify behavioral and genetic predispositions to childhood obesity in a high-risk sample of predominantly minority children from low-resource backgrounds. Identifying protective factors that may mitigate the impact of obesity risk on weight and adiposity outcomes is critical for moving the prevention of childhood obesity into a new direction.